dkNET Coordinating Unit: An information network for FAIR resources and data

Project Summary
As the NIDDK Information Network (dkNET) Coordinating Unit we must develop strategies to ensure that dkNET
continuously evolves to meet community needs. As the use of a wide-array of methods that generate large
amounts of complex data become more common in biomedical research, there is a growing need to develop an
interdisciplinary workforce that can use and further refine computational and statistical approaches to interrogate
this high-content data. The New Investigator Bioinformatics Pilot program will: (i) facilitate the ability of Early
Stage and New Principal Investigators with computational and bioinformatics expertise to pursue research
questions in Diabetes, Endocrinology or Metabolic Diseases, or (ii) allow Early Stage and New PIs currently
pursuing research in these NIDDK topic areas to explore incorporating computational, statistical, and/or
bioinformatics approaches into their research projects. The overall goal of this dkNET Pilot Award program is
to provide support for these early career investigators to obtain feasibility data in support of future grant
applications.

Public health relevance
Project Narrative As the use of a wide-array of methods that generate large amounts of complex data become more common in biomedical research, there is a growing need to develop an interdisciplinary workforce that can use and further refine computational and statistical approaches to interrogate this high-content data. The NIDDK Information Network (dkNET) New Investigator Bioinformatics Pilot program will facilitate the ability of Early Stage and New Principal Investigators with computational and bioinformatics expertise to pursue such research in Diabetes, Endocrinology or Metabolic Diseases.